Development of PARP-Isoform Selective Inhibitory Chemical Probes

Project Summary/Abstract
The development of highly isoform-selective poly(ADP-ribose) polymerase (PARP) biochemical probes will fill
crucial knowledge gaps that exist in our understanding of biological functions of PARP enzymes. PARPs are a
family of nuclear enzymes that catalyze poly(ADP-ribosyl)ation (PARylation) of substrate proteins such as
histones. PARylation facilitates recruitment of DNA repair proteins. Consequently, PARP inhibitors (PARPi) are
developed as a novel class of anticancer drugs that are used as single agents to treat BRCA-deficient tumors
and as combination therapy with DNA damaging agents. The PARP superfamily is comprised of 17 members.
Clinical PARPi are often associated with promiscuous inhibition of both PARP-1 and PARP-2 and some of them
even inhibit other PARPs. This becomes a potential cause for their off-target hematologic toxicity. Due to non-
specific targeting of multiple PARP-isoforms by currently known PARPi, a thorough interpretation of their
pharmacological/clinical profiles has become highly complex. Further it was shown that PARP-1 inhibition alone
is sufficient to repress the growth of MDA-MB-436 tumor xenograft. Depletion of both PARP-1 and PARP-2 led
to embryonic lethality and aggressive T-cell lymphomas. One of the challenges impeding evaluation of PARP-
isoform specific molecular interaction landscape in cellular context is the lack of potent and highly PARP-isoform
selective chemical probes. Therefore, development of highly isoform selective PARP inhibitory probes is urgently
needed. Weplan to address this by developing isoform-selective and potentially non-toxic novel PARP inhibitory
chemical probes that will allow interrogation of changes in downstream signaling events of individual PARPs at
a molecular level. The probes generated herein will also serve as template for the next generation preclinical
agents. We will apply highly potent and novel set of UTT-lead compounds to develop exquisitely PARP-isoform
selective chemical probes that will facilitate our understanding of biological functions of individual PARPs in both
normal and diseased cells. As a proof-of-concept, we have synthesized and characterized several PARPi with
nanomolar potency against both PARP-1 and PARP-2, with ~30-fold higher preference toward PARP-2. Based
on this scientific premise and preliminary data, we propose the following specific aims: (A) to identify PARP-1
and PARP-2 selective biochemical probes; (B) to conduct in vitro PARP enzyme assays and isoform selectivity
screening, and (C) to evaluate cytotoxicity of an isoform selective best PARPi in CAPAN-1 (BRCA2-/- and
BRCA2cor) and SUM149 (BRCA1-/- and BRCA1cor) cells. These studies are expected to expand our knowledge
on the impact of inhibiting a specific PARP-isoform by developed PARP chemical probes. By the end of the grant
project period, we will be poised to evaluate cell-active and highly PARP-selective chemical probes in high value
cell-based experiments. Subsequently, we plan to investigate PARP-isoform specific downstream signaling
events, identification of new PARylated substrate proteins, on-target engagement and phenotypic change, and
to validate if other PARPs are viable pharmacological targets.

Public health relevance
Public Health Relevance/Narrative Clinical PARP inhibitors used for the treatment of DNA damage repair defective cancers suffer from non-selective inhibition of multiple PARP enzymes, and this leads to highly undesirable hematologic toxicity. Our current understanding of in-depth signaling mechanisms exerted by individual PARP enzymeremains poorly understood because highly selective PARP-specific chemical probes remain undeveloped. The proposed research will develop novel chemical probes with exquisite selectivity toward PARP-1 and PARP-2 enzymes that can be utilized to advance our current understanding of individual PARPs in normal and diseased cells; this could help develop novel PARP-targeted anticancer agents with reduced toxicity.